The role of endothelial connexins in vascular wound repair

|| Project Summary .
Impaired endothelial wound healing in blood vessels like the coronary artery and saphenous vein is a primary
contributor to vascular stent failure and deadly coronary thrombosis. Identifying the mechanism of delayed
endothelial repair is essential for improving vessel patency and patient survival rates. As such, this proposal
focuses on identifying regulators of normal endothelial healing and understanding how these factors are
dysregulated when healing is impaired. Previous studies have shown connexin 43 (Cx43) gap junctions may
regulate wound healing. However, the specific role of connexin 43 in endothelial cell (EC) healing is unknown.
Preliminary data in this proposal indicates that ligation-induced vascular injury promotes increases in the
expression of EC Cx43 surrounding the damaged area in the aorta and carotid arteries in mice. Cx43-mediated
gap junction intracellular communication is controlled by phosphorylation at the Cx43 C-terminus. My preliminary
data demonstrate that specific Cx43 phosphorylation at its serine (s) 368, associated with gap junction closure,
is present during the final stages of EC wound healing in vivo. Cx43-s368 also reduced the rate of wound closure
in cultured human EC. These findings inform the hypothesis that Cx43 expression and channel functions are
critical for EC wound healing in large arteries. The aims of this proposal are to define the role of connexin 43 in
endothelial wound healing (Aim 1), investigate if a loss of Cx43 limits healing in vivo (Aim 1), and test if channel
functions, regulated by posttranslational modifications, improve/delay vascular repair (Aim 2). This investigation
will be completed using a novel mouse carotid EC injury survival surgery in mice I developed, which will allow
for the assessment of Cx43 expression in carotid EC during the healing process. Both genetic and
pharmacological strategies will be used to alter Cx43 expression and phosphorylation in mouse injury models
and in cultured human EC, and the impact of these modifications on the rate and quality of EC healing will be
quantified. Additionally, RNAseq approaches will be used to identify Cx43 gap junction-dependent signaling in
the regenerating endothelium. These aims will be accomplished under the mentorship of researchers with
extensive experience in vascular biology, Dr. Scott Johnstone, Dr. Robert Gourdie, and Dr. Brant Isakson, at
Virginia Tech’s Fralin Biomedical Research Institute (FBRI). The FBRI is home to research equipment including
but not limited to animal facilities, confocal microscopes, flow cytometers, and cell culture equipment. This state-
of-the-art research environment will allow for a detailed and mechanistic investigation. Ultimately, this study will
characterize a novel role for Cx43 in vascular EC. This project is designed to identify new potential therapeutic
targets in vascular disease that will promote the mission of the NIH to enhance patient health and to promote
longer life free of illness.

Public health relevance
|| Project Narrative Lifesaving surgeries in blood vessels of the heart often fail due to poor or delayed healing of cells lining the blood vessel wall, putting patients at risk for stroke, heart attack, and death. My proposal aims to understand what controls the cells during healing and to identify ways to improve blood vessel repair. In the long term, my research aims to provide information that could be used to create therapies to reduce disease burden and increase patient survival.